Integrated bioprinting and optogenetics platform for evaluating neural activity in stem cell-derived retinal disease models

PROJECT SUMMARY
A major obstacle in studying retinal degenerative disorders lies in accurately modeling their pathophysiology
from the cellular to the systems level in a benchtop lab setting. Although animal models provide valuable insight
into disease processes in vivo, ethical and technical limitations often prevent the full translation of experimental
findings into the clinical context. Recent advances in tissue engineering – particularly in 3D bioprinting and
human induced pluripotent stem cell (hiPSC)-derived neural populations – provide new approaches for
investigating neuropathology in vitro. Emerging evidence suggests that when compared to 2D substrates,
biocompatible 3D hydrogel microenvironments more accurately portray normal physiologic and pathologic neural
states. However, patterning 3D tissues and probing their electrical activity are not trivial and pose challenges for
elucidating the relationships between cell physiology, emergent electrochemical signaling behavior, and higher-
level computation and cognition. While multi-electrode arrays (MEAs), optogenetic stimulation, and voltage-
sensitive fluorescent imaging are well-established techniques for interrogating native in vivo neural activity, their
application towards in vitro 3D systems has been limited.
This R21 project aims to develop a novel, high-throughput optical projection platform to create “visual-circuit-on-
a-chip” by integrating 3D bioprinting, optogenetic stimulation, MEA recording, and real-time fluorescence
imaging. In Specific Aim 1, we will develop an integrated platform for bioprinting, electrophysiology, and
multiwavelength optogenetic stimulation. The bioprinting method allows for projection printing into conventional
cell culture plates as well as single-well and multi-well MEA substrates. Using photopolymerizable extracellular
matrix mimics, we will encapsulate hiPSC-derived neural progenitor cells and induced neurons to direct cell
proliferation, neurite outgrowth, and functional connectivity. In Specific Aim 2, we will implement hiPSC
technology to enable spatiotemporal control of induced multicellular differentiation and optogenetic stimulation.
We will build simplified neural circuits first, then extend into a more comprehensive visual circuit platform utilizing
hiPSCs engineered to produce specific populations of induced retinal neurons. Our combined technical
capabilities will allow us to integrate these experimental methods into a novel all-in-one platform to yield high-
throughput fabrication and interrogation of systematically patterned and stimulated biological neural networks.

Public health relevance
Narrative Neurodegenerative diseases (including retinal degenerations) contribute a substantial socioeconomic burden in terms of functional impairment, lost productivity, and associated medical care and treatment. This project aims to develop a platform technology by integrating 3D bioprinting and opto-neurotechnology to create brain/retina-on-a-chip" devices toward the diagnosis of neurological disorders.